Mechanisms of Beta Amyloid-Induced Synaptic Dysfunction

Project Summary Alzheimer’s Disease (AD) is a prevalent neurodegenerative disease and the leading cause of age- related dementia. While the pathologic agent that causes AD remains controversial (Aβ vs. Tau) strong genetic, biochemical, anatomical and electrophysiological evidence have established that Aβ causes significant synapse loss and blocks induction of long-term potentiation (LTP), a form of plasticity critical for learning and memory. Soluble Aβ oligomers bind directly to excitatory synapses, but a significant fraction (~30- 40%) of synapses remain unbound. Correspondingly, a subset of synapses are spared from Aβ-triggered elimination, but the relationship between Aβ binding and elimination remains a fundamental question. Intriguingly, Aβ-mediated synapse loss requires activation of NMDA-type glutamate receptors (NMDARs), which gate Ca2+, a key second messenger for important forms of synaptic plasticity, including LTP. While pharmacologically blocking NMDARs prevents Aβ-induced synapse loss (suggesting that Aβ induces a gain of NMDAR function), Aβ also potently blocks LTP, suggesting that Aβ impairs NMDAR function, or downstream NMDAR signaling. Together, these results provide compelling evidence that NMDARs are a central mediator of Aβ-induced synaptotoxicity, yet there is a major gap in our understanding of how or whether Aβ influences NMDAR function. Furthermore, whether local synaptic activity plays a role in Aβ binding to synapses and whether only those synapses bound by Aβ are eventually eliminated remain fundamental questions. I will use a novel live cell imaging technique to assess changes in NMDAR function in response to Aβ at individual synaptic sites.

Public health relevance
Project Narrative Synaptic plasticity is thought to be the cellular correlate that underlies learning and memory and is disrupted in numerous disorders and diseases including Alzheimer’s Disease (AD). This proposal will investigate how the AD-associated protein, Beta Amyloid, affects proteins essential for synaptic plasticity and how these changes may result in the reduced number of neuronal connections seen in AD brains.